Prenatal alcohol exposure and corticostriatal mediation of behavioral flexibility

Abstract
There is growing evidence that moderate exposure to alcohol during development can lead to behavioral and
cognitive deficits that can persist throughout the lifespan. Cognitive impairments associated with Fetal Alcohol
Spectrum Disorders (FASD) include abnormalities in learning and memory, executive control and social
behaviors and are often characterized by a hyper-focus on one particular task or aspect of a task, to the
detriment of other important behaviors. We have recently shown that moderate prenatal alcohol exposure
(PAE) can impair executive control in adulthood and that behavioral impairments are accompanied by
significant alterations in coherence in the orbitofrontal cortex during choice. Both behavioral deficits and
cortical alterations are found when GluN2B subunit containing N-Methyl-D-Aspartate receptors (NMDAR) are
lost in the OFC. Given preliminary data that GluN2B is significantly reduced in the OFC after PAE, we propose
to investigate whether impairments in behavioral flexibility are driven by alterations in cortical coherence
mediated by alterations in NMDAR expression and function and whether these deficits can be rescued. We
propose to integrate a well-established voluntary drinking paradigms for moderate PAE with touch-screen
behavioral assays, in vivo and ex vivo electrophysiology and optogenetic stimulation. First, we will express
channel rhodopsin (ChR2) in the cortex of PAE and SAC mice and examine whether direct stimulation will
rescue behavioral flexibility impairments in PAE mice. Next, given evidence that GluN2B is downregulated
after PAE and that his subunit contributes to establishing cortical coherence, we will investigate whether
behavioral deficits in the model are mediated by alterations in GluN2B subunit expression and recruitment
required to induce plasticity and support behavioral flexibility. Finally, we will examine whether changes in
connectivity between OFC and dS drives asynchrony and perseveration. We will use retrograde expression to
fluorescently tag OFC-dS neurons and characterize function of NMDAR via ex vivo slice physiology. Then we
will utilize retrograde expression of ChR2 to test if stimulation restricted to OFC-dS neurons is sufficient to
rescue the behavioral deficits. Taken together the completion of these aims will elucidate the mechanisms of
cognitive impairment in FASD and provide an important tool for developing more effective therapies for
executive dysfunction.

Public health relevance
Project Narrative There is growing evidence that moderate prenatal alcohol exposure can lead to behavioral and cognitive deficits that can persist throughout the lifespan. However, little is known regarding the mechanisms responsible for these deficits in Fetal Alcohol Spectrum Disorder. This project seeks to understand how prenatal alcohol exposure disrupts normal brain circuitry leading to behavioral impairments, and test potential avenues of rescuing these deficits.